Engaging All of Us for Effective Precision Medicine

The University of Utah and its community partners will bring a combination of experience and expertise that is well-suited to
developing and evaluating impactful engagements for the All of Us Research Program. Key highlights from the details provided
elsewhere in this proposal:
Genetic Science Learning Center (GSLC) at the University of Utah
• Multi-talented team of 18 with a combination of science, education, science and health writing, visualization, and
evaluation expertise
• 20 years of experience in using community-based participatory design approaches to develop materials, including
with underrepresented communities
• Experts in making complex science—including genetics, genomics, and personalized medicine—understandable for
non-experts, with a focus on grade 5-10, patients, the public, and providers
• Award-winning, creative approaches to developing digital, experiential, and multicultural materials
• Developers of Learn.Genetics and Teach.Genetics, the most highly used life-science education websites in the world
• Rigorous evaluation methods used to assess the efficacy of and iteratively improve materials we develop
• Passionate about our mission of making science and health easy for everyone to understand
Community Partners
Community Faces of Utah (CFU)
• Equitable collaborative among leaders of 5 diverse community organizations, the Utah Department of Health, and the
University of Utah, established in 2009; each community leader leads a network of other organizations
• Committed to improving health in the African refugee/immigrant, African American, American Indian/Alaskan Native,
Hispanic/Latino (Latinx), and Pacific Islander communities
• Began with projects to develop educational materials and programs focused on genetics and health
• Experienced in community-based, participatory design and co-creation of materials, programs, and research studies
Equality Utah
• Seeks to secure equal rights and protections for lesbian, gay, bisexual, transgender & queer Utahns and their families
• Has collaborated with CFU, researchers and CCET in conducting research studies
Community Collaboration & Engagement Team (CCET) of the Utah Center for Clinical & Translational Science (CCTS)
• Sensitively facilitates academic-community partnerships; 10 years of experience
• Skilled at building trusting relationships with community leaders, organizations and members
• Supports multi-directional learning throughout projects
• Has developed and maintains relationships at the local, state, regional and national levels with a strong focus on
underrepresented groups
Therapeutic Games and Apps Lab (GApp Lab), Entertainment Arts & Engineering Program (EAE), University of Utah (EAE)
• One of the top game development programs in the world; BS and MS degrees
• GApp Lab involves graduate students in developing health-related games and apps
• Established collaboration between GSLC and EAE/GApp Lab for developing digital engagements

Public health relevance
No Text